STRUCTURE-ACTIVITY RELATIONSHIPS AMONG PROTEINS

The central goals of this proposal concern the relationship between protein structure and protein function. The powerful techniques of recombinant DNA technology will be applied by four investigators to study distinct groups of biologically important macromolecules. Most of these molecules are involved in cell-cell communication and in most instances, DNA probes are available to allow a more global approach to a full appreciation of the synthesis, expression and activity of a particular protein. The Program Project mechanism is requested as the technologies required to carry out each individual project require not only the intense intellectual interaction presently taking place, but, in addition, the pooling of resources and equipment. All the studies largely involve protocols in the mouse and rat, although the results of these projects will have clear applications to man.